Testing a pre-visit mobile health app to promote adolescent healthcare

ABSTRACT
While preventive care guidance recommends primary care providers deliver sexual and reproductive health
(SRH) care to male adolescents (ages 12 and older), males’ SRH care receipt is poor. Clinic-based
interventions can be valuable SRH promotion tools for adolescents. However, they have mainly focused on
pregnancy prevention for females, single topics (STIs, HIV) rather than the recommended SRH care package,
or specific male groups (e.g., men who have sex with men) rather than inclusive of the diversity of males
encompassing the full range of gender identities, sexual orientation, race/ethnicity, and risk behaviors.
Computer-based approaches make it easier to consistently provide evidence-based SRH, in multiple
languages, tailored to the diverse needs of all adolescents. Using such approaches before the clinic visit can
also help overcome providers’ barriers, such as time constraints, to improve SRH care. Yet, we are not aware
of any computer-based strategy to promote recommended SRH care for diverse groups of males. Neglecting
males in evidence-based SRH care fails to meet their own needs, and compromises their partners’ health.
Health-E You/Salud iTu is a pre-visit, individually tailored, interactive, web-based mobile intervention
shown to improve contraceptive knowledge and use among adolescent females 6 months later and prime and
extend providers’ ability to deliver individually tailored contraceptive care to female patients. We will adapt the
current Health-E You for male adolescents to assess their SRH needs; provide interactive, individually tailored,
evidence-based SRH information; support SRH decision-making and visit priorities; and support providers’
ability to individually tailor recommended SRH care. We will then evaluate its acceptability, usability,
satisfaction, and efficacy on SRH care receipt and method use among diverse groups of male adolescents
presenting for care at school-based health centers (SBHCs), by leveraging the infrastructure of a current
PCORI-funded trial with 28 SBHCs in 11 states focused on assigned females sex at birth. It will also support
providers in delivering the recommended SRH care package for males. In this R01 proposal, we propose to (1)
adapt Health-E You as a pre-visit, individually tailored, interactive, SRH care tool for use with diverse groups of
male adolescents employing a Youth-Centered Health Design Process with input from an advisory board of
male adolescents and providers; (2) ensure its acceptability, usability, and satisfaction among male adolescent
patients and providers in SBHCs using an iterative design approach; and (3) test its efficacy to improve
sexually active male adolescent patients’ knowledge, self-efficacy, beliefs, and behaviors related to SRH care
after the visit and method use 2 months later. The current proposal would be the first to examine the
acceptability, usability, satisfaction, and efficacy of a pre-visit, computer-based intervention to engage sexually
active male adolescent patients in SRH care and method use, where currently no such strategy exists.

Public health relevance
NARRATIVE Male adolescents have substantial sexual and reproductive health (SRH) needs, including high rates of sexually transmitted infections, human immunodeficiency virus, cancer prevention, and unintended partner pregnancies; yet despite clinical guidelines that recommend primary care providers deliver SRH care to all male adolescents, very few males receive any singular SRH service. Computer- and clinic-based strategies have potential to address this gap, but to date, there are not any approaches that promote the recommended SRH care package for diverse groups of males presenting to care. This project will adapt Health-E You/Salud iTu, a pre-visit, individually tailored, web-based mobile app that improved female adolescents’ contraceptive knowledge and contraceptive care receipt, for use with diverse male adolescents; and will examine its acceptability, usability, and satisfaction among male adolescents and providers; and its efficacy on improving male adolescents’ knowledge, self-efficacy, beliefs, and behaviors about SRH care after the visit and method use 2 months later.